Admin Core

PROJECT SUMMARY
The Administrative Core (AC, Limbrick Lead) will execute the Center’s objectives, ensuring that all research and
programmatic goals are met. It will provide executive oversight, administrative support, and coordination for all
Cores and Projects using efficient communication and good project management practices. The overarching
goal of the Administrative Core is to leverage the intellectual and financial resources of the individual Cores and
Projects to maximize overall scientific productivity. The AC will address the following Specific Aims:
1. Establish and maintain administrative structure and governance over PRCSC and all Cores and Projects.
2. Establish a Steering Committee to oversee PRCSC priorities, milestone achievements, and long-term
strategic plan.
3. Establish an Internal Advisory Committee for strategic oversight and conflict resolution.
4. Provide for annual review of PRCSC by an External Advisory Committee (EAC).
5. Coordinate all PRCSC research and related activities among Cores, Projects, Committees, and the
community through efficient communication.
6. Authenticate regulatory compliance of PRCSC across all scientific research and educational missions.
7. Provide budgetary oversight to ensure optimal resource utilization across PRCSC and all Cores and
Projects.
8. Promote scientific and educational interactions on CM and related conditions.